mHealth for Patient Self-Management of Opioid Use Disorder - Administrative Supplement

PROJECT SUMMARY / ABSTRACT
The opioid crisis is an epidemic with devastating health, social, and economic consequences for
the United States. From 1999–2018, almost 450,000 people died from an overdose involving an opioid,
including prescription and illicit opioids. Three million US citizens and 16 million individuals worldwide
have had or currently suffer from opioid use disorder (OUD). The total economic burden of the opioid
crisis in the US is estimated to be more than $200 billion annually.
Treatment for OUD involves medication assisted treatment (MAT) combined with counseling or
behavioral therapy to manage the illness, achieve and sustain better health, and improve quality of life.
Rates of recurrent drug use are high, and access to counseling is limited and costly. While MAT is
standard of care and highly effective at reducing acute morbidity and mortality, there are advantages to
treatment approaches tailored to address an individual patient’s drug use patterns and drug-related
medical, psychiatric, and social problems. While mobile tools exist to support OUD treatment, these
products offer only generalized information and not personalized feedback that is responsive to each
person’s current status to support their individual recovery.
In Phase I, we developed KIOS, an innovative software platform using nonlinear control theory.
KIOS tracks multiple interacting symptoms (e.g., craving, mood, pain) to map patient trajectories and
deliver timely evidence-based intervention strategies, responding directly to patient-reported needs.
Accessible via mobile devices, KIOS provides patients on demand individualized advice and
reinforcement of lifestyle interventions to improve self-management during MAT. Phase I beta testing
demonstrated significant reductions in key symptoms of OUD and high levels of engagement, usability
and patient satisfaction.
In Phase II studies, we are evaluating KIOS as a prescription digital health therapeutic suitable
for FDA approval concomitant to MAT to treat OUD. The Phase II study contains a 12-week randomized
controlled trial designed to satisfy requirements to receive FDA 510(k) clearance. Correspondence with
the FDA has led to an expansion of the clinical trial to now include a sham app as a comparator to KIOS.
This unexpected addition to the clinical trial has led to the filing of this administrative supplement to
develop and test the sham app for use in a randomized controlled trial.

Public health relevance
PROJECT NARRATIVE Behavioral therapy is an important adjunct to medication assisted treatment for opioid use disorder. Currently available mobile tools to deliver behavioral interventions are limited in their ability to respond to changing conditions of individuals in recovery. This project seeks to develop and confirm the validity of a sham app comparator to aid in testing the efficacy of the digital therapeutic. It is a supplement to a funded project to develop an on-demand delivery of mobile intervention strategies responsive to patients’ specific needs that if successful, would improve outcomes, reduce healthcare costs, and have a significant impact on public health.